An Enriched, Immersive Rehabilitative Environment for Those with Traumatic Brain Injury

PROJECT SUMMARY
Severe traumatic brain injury (sTBI) can lead to permanent motor and cognitive deficits and often result
in exclusion from participation in society. Recovery of function through neurotherapy can continue years after
the injury. However, it is a slow process in a sterile environment and difficult to integrate into one’s life. For
decades, the concept of enriched environments, that is, scenarios that combine cognitive, social and physical
stimuli, have shown neuroplastic benefits in animal models. Recent calls have been made to translate
environmental enrichment to humans. Our long-term goal is to combine the principles of enriched
environments and vocational reintegration for an immersive therapy for adults with sTBI. This project continues
our work on the therapeutic café, a multimodal platform which combines therapies and first-phase vocational
training. In this proposed work, we will recruit chronic sTBI survivors to participate in a randomized controlled
pilot experiment that compares immersive therapy in the café to conventional physical and occupational
therapy. The participants in the immersive group will participate in a fully functioning kiosk located at the
MetroHealth Rehabilitation Institute cafeteria over a six-week training program under the supervision of a
therapist. The kiosk is equipped with a harness to protect from falls and is stocked with hot and cold
refreshments. Participants will interact with customers, collect payment, restock items and clean the area, all
with guidance from the therapist. The conventional therapy group will participate in physical and occupational
therapy for an equivalent duration as the immersive group. Our goal is to compare immersive to conventional
therapy to obtain preliminary data for a larger clinical trial. In Aim 1, we compare the differences in two therapy
strategies based on clinical measures of gait, balance, upper limb movement and function, and cognition. In
Aim 2, we examine the differences in physical activity between groups by quantifying limb and joint motion with
wearable sensors. We expect to find that for the same amount of motion, immersive therapy results in greater
improvements in clinical measures because it engages speech, cognition, and physical function in a real-world
manner. This work is important because it uses a randomized controlled trial to evaluate an innovative
motivating, real-world, vocational therapy option for people with the most severe level of TBI. This is innovative
as it is a completely new platform for combining therapeutic gains and community participation in this
population. The work also helps define how to quantify the amount of therapy activities and illustrates how it
can be used to understand the relationship between physical activity and clinical outcomes.

Public health relevance
PROJECT NARRATIVE There is an increasing call for real-world relevance in neurorehabilitation including the rehabilitation of people following severe traumatic brain injury (sTBI). Enriched environments have the potential to provide a sustainably motivating, social and multimodal therapy platform. This project will quantify the efficacy of training people with chronic sTBI in the enriched environment of a therapeutic café as compared to conventional therapy.